Radioresistant Innate Immunity in SAVI Tissue-Specific Autoinflammation

The cGas/STING cytosolic DNA sensing pathway detects microbial DNA and plays a critical role in host defense.
Growing evidence indicates that self-DNA that accumulates in the cytosol also engages cGAS to incite
inflammation. In addition, a series of gain-of-function mutations that result in constitutive activation of STING
have now been associated with a debilitating auto-inflammatory disease known as SAVI (STING-Associated-
Vasculopathy with onset in Infancy). These patients suffer from severe vasculitic lesions and progressive
interstitial lung disease (ILD), and frequently succumb to treatment-resistant ILD-associated with fibrosis. Similar
to the lung disorders associated with other inflammatory or fibrotic lung diseases, very little is known about the
pathogenic mechanisms in these patients. Thus, a better understanding of the mechanisms responsible for these
conditions is needed in order to develop more effective therapies. We have recently developed a murine model
for the most common SAVI mutation, STINGV154M (VM), and shown that these mice recapitulate the human
disease by a variety of criteria, including the development of inflammatory/fibrotic lung disease. These VM mice
provide a unique experimental tool for exploring the cell types and molecular mechanisms responsible for the
initiation and progression of fibrotic lung disease. Rag1-deficiency completely rescues VM mice from both lung
inflammation and lung fibrosis pointing to a critical role of the adaptive immunity in VM ILD. The role of STING
has been focused on myeloid cells and VM mice have an expanded and activated myeloid/neutrophil
compartment. However, radiation chimera studies have identified a key role for radioresistant cells in lung fibrosis
as lethally irradiated VM mice reconstituted with WT bone marrow stem cells develop extremely severe lung
disease even though these chimeras completely lack any VM-derived hematopoietic cells. Preliminary data
implicate lymphatic endothelial cells (LECs) as initiators of BALT formation in VM mice. The goal of this
application is to further explore the radioresistant innate immune cells that are directly or indirectly activated by
the VM mutation and define the mechanisms by which these cells promote lung inflammation. Our approach will
involve: (1) the in vivo analysis of a novel VM conditional KI line crossed to endothelial-restricted Cre deleter
strains and other relevant controls, (2) scRNAseq comparison of stromal populations including lymphatic and
vascular endothelial cells isolated from WT and VM mice; and (3) analysis of endothelial cells from VM and WT
mice following in vitro activation by the VM mutation or more conventional STING agonists. There is an urgent
need to identify better therapies for patients afflicted with autoimmune and autoinflammatory lung disorders and
the studies proposed in this application should provide critical insights that will enable us to design the most
relevant therapeutic targets. Further, these studies provide an opportunity to study the impact of STING
activation on stromal cell types more generally, an emerging area of research as STING activity in endothelial
cells has recently been linked to the development of severe COVID19.

Public health relevance
NARRATIVE Autoimmune and autoinflammatory diseases afflict 7-9% of the world population, and the goal of this project is to understand how the cytosolic cGAS/STING DNA sensing pathways contributes to these potentially devastating diseases so that we can better control them. This project draws on investigators with complementary expertise and will apply exciting new tools and strategies to study how innate immune responses in non- hematopoietic cells can promote lung complications. Insights resulting from this project should give us an opportunity to develop better treatment strategies for the many patients who suffer from interstitial lung disease.